Dissecting the cellular and spatial tissue clock of the human lung and peripheral blood

PROJECT SUMMARY
With the unprecedented increase in age of the global population, there is a critical need for improving our
understanding of the cellular, molecular, and spatial tissue underpinnings of aging biology. New insight into the
age-related mechanisms and pathways in the human lung have the potential to uncover new therapeutic
opportunities to modulate the cellular microenvironment, decelerate the lung aging process, and decrease the
susceptibility of the elderly to numerous respiratory diseases. We propose to combine highly-parallelized,
single-cell RNA-sequencing (scRNA-seq) and spatial transcriptomics profiling with advanced computational
analyses to characterize the effect of age on the human lung and peripheral blood cellular microenvironment.
As part of the Human Lung Cell Atlas network, we have helped build an integrated scRNA-seq census of
hundreds of healthy individuals. The integrated scRNA-seq data set will provide us with the necessary
statistical power to decipher the cell composition, cell type expression, and regulatory differences between
different age groups of healthy lung and blood donors. We will also use machine learning to model the effect of
cell type specific immunomodulators/pathways on lung cell compostion and to identify novel therapeutic targets
in order to better understand the underlying aging mechanisms and how they associate with age. Finally, we
will validate our computational modeling by measuring the spatial cellular organization of normal lung tissue
samples spanning different age groups as well as testing the anti-aging effect of the most promising
therapeutic targets on lung function and cellular communication. Our study promises to improve our
understanding of the effect of age on cell-cell interactions, gene expression programs, and multicellular
communities in the human lung and peripheral blood, identify/validate new treatment strategies, and uncover
new biomarkers that can improve the quality of life for elderly individuals. Finally, our data-driven,
computational approach can be extended to study the relationship between age and the cellular
microenvironment in other tissues or organs and help combat the effect of aging throughtout the human body.

Public health relevance
PROJECT NARRATIVE This proposal seeks to better understand how age affects the cellular microenvironment of the lung and blood using human samples, which has primarily been studied in mouse models to date and without the use of single-cell resolution technologies. Our approach will combine single-cell transcriptomic data and age information from hundreds of samples with spatially-resolved measurements of lung tissue organization and machine learning to uncover and validate age-specific cell frequencies, gene expression programs, cell interactions, spatially resolved multicellular communities, and therapeutic targets that can delay age-related decline in lung function. Our computational methodology can be used to study the relationship between age and the cellular microenvironment in other human tissues or organs.